Mentoring Core

PROJECT ABSTRACT
The K-INBRE network proposes a Mentoring Core to stimulate basic and translational research in Cell
and Developmental Biology in Kansas via mentored, interdisciplinary research opportunities. The Mentoring
Core will execute and oversee 3 mentored training programs that have been successful within the K-INBRE
Network in the past funding periods. These include the Partnership for Translational Research Program, the
Developmental Research Project Program (DRPP), and the Postdoctoral Research Fellowships. All 3 programs
will promote the development of multidisciplinary research projects in the area of cell and developmental biology,
with the specific focus of: 1) promoting avenues whereby scientific skills and knowledge essential to translational
research are transferred between a basic scientist and a clinical researcher to bring basic knowledge to the
bedside, 2) supporting promising postdoctoral fellows as they develop tools and skills to advance in their careers,
and 3) providing young faculty with the skills to acquire independent funding. The Partnerships for Translational
Research Program will enhance translational research skills by pairing basic scientists with clinical research
faculty. The main components of this program are pilot grants awarded to research teams composed of a clinician
and a basic scientist. These partnerships are characterized by cross-training between the two partners, with
basic scientists bringing expertise in research design and bench laboratory methods to the table, while the
physician partner offers guidance as to the most useful clinical application for the research discoveries. The
Mentoring Core will provide oversight, feedback and be the principle evaluator for this program. The Postdoctoral
Research Fellowships support promising postdoctoral fellows as they develop an interdisciplinary research
project and acquire leadership skills that will help promote their independence as new investigators. This
program encourages the writing of grant applications to support post-doctoral training from other funding
sources. These awards are valuable since they provide financial support to laboratories, educate and ensure
training in grant-writing skills, and ensure that excellent mentoring is provided during the critically important step
of developing research careers. The DRPP supports and mentors new faculty engaged in interdisciplinary
developmental research projects. Faculty members will be identified and supported for a standalone project
falling within Cell and Developmental Biology. An engaged, primary mentor will be identified for each awardee,
and the Mentoring Core will identify and evaluate milestones specific to each project. Progress will be monitored
closely by the Mentoring Core Director, in conjunction with the mentor, and funding for the 2nd year will be
contingent upon adequate progress in the 1st year.